"Structural Dynamics of Molecular Motors and the Ribosome" The studies proposed will give basic information on gene expression, cellular development, and transport motor function in cell biology.

Summary
Protein synthesis and active transport of vesicular cargoes are vital to development of all tissues and to the
targeted delivery of organelles, proteins, and signaling molecules in eukaryotes. Accordingly, defects in protein
expression and transport are linked to developmental, neurodegenerative, pigmentation, immunological, and
other diseases. Knowing the detailed mechano-chemistry and structural dynamics of the ribosome and motor
proteins is essential for understanding and interpreting their roles in the cell. We have developed a number of
powerful new biophysical tools that reveal the structural dynamics and reaction kinetics of the protein synthesis
elongation cycle and cargo transport in muscle and non-muscle molecular motors under applied mechanical
force. We will apply these unique tools to investigate the rhythm of protein synthesis and premature termination
in eukaryotes. We will elucidate the divergent biochemical and mechanical properties of skeletal muscle myosin
and non-muscle myosins-I, V, VI and X. Understanding functional dynamics and mechanistic detail that have not
yet previously been accessible is now feasible. This MIRA grant coalesced 3 former NIH grants: the applicant's
section of a program project on molecular motors in cells, an individual R01 grant to the applicant on basic
biophysical mechanisms of molecular motors, and a multi-PI grant on protein synthesis. The links between all of
these different topics are that they are subject to formidable study by single molecule biophysics approaches
and they incorporate P-loop NTPases with many common structural motifs and principles. They can be under-
stood synergistically by studying and comparing their individual structural, energetic and dynamic features. Ex-
amples of this synergy are given in the body of the application. For the renewal period we plan to 1) continue the
successful development of state-of-the-art single molecule fluorescence and optical trap technology, 2) apply
these methods to a series of myosin isoforms that have been described in the literature as having qualitatively
different properties, 3) build a new class of intracellular force-FRET sensors for studying mechanobiological
signaling from the peripheral environment of a cell to control of gene expression in the nucleus, 4) compare and
contrast mechanisms of eukaryotic protein synthesis with the bacterial system, 5) elucidate the detailed mecha-
nisms for enhancement, during protein synthesis, of premature termination codon (PTC) read-through by phar-
maceuticals that are candidates for therapy in PTC diseases (e.g. Duchenne muscular dystrophy and cystic
fibrosis,) and 5) a new venture to test processive translocation by AAA+ domain ring proteins, including Hsp104
(which disaggregates toxic amyloid proteins) and katanin (which modulates microtubule length by severing and
is also tied to diseases). Overall, these studies will lead to a much more general view of the mechanisms and
characteristics of the ribosome and molecular motors in vitro and in live cells leading to a more rigorous under-
standing of their functions in cell biology and disease.

Public health relevance
Project Narrative (Public Health Relevance) Protein synthesis on the ribosome and intracellular motility and cell division, based on the molecular motors are crucial for development and maintenance of all of the organs in the body. The specific cellular machines to be studied here, the ribosome, myosins, and cytoplasmic filaments, are required for appropriate neuronal development, sensorineural function in hearing and eyesight, the immune response and cell division. Thus errors of expression or function lead to severe developmental neurological, cardiovascular, immunological deficits, and play roles in cancer cell division and metastasis, muscular dystrophy, cystic fibrosis and many other diseases. The studies proposed here will give fundamental information on how gene expression, cellular development, and transport motors function and may eventually lead to therapeutic targets in these diseases.